Optimizing CAR T therapy via metabolic engineering for thetreatment of GBM

PROJECT SUMMARY AND ABSTRACT
Significance: Glioblastoma (GBM) is an extremely devastating disease with reported median survivals ranging
from 13 to 73 months and 5-year survivals of less than 20% in children and about 15 months with less than 5%
5-year survival rate for adult patients. Cancer immunotherapy using chimeric antigen receptor (CAR) modified T
cells is a promising treatment, however its efficacy in GBM has been limited.
Hypothesis: We hypothesize that the fierce competition for nutrients within the tumor microenvironment,
especially glucose, between tumor cells and the immune system, imposes an abundant metabolic pressure to
CAR T cells dampening their effector function and intratumoral infiltration, expansion, and persistence.
Objective: The goal of this study is to validate a new strategy to overcome this metabolic imbalance and provide
a competitive advantage to CAR T cells over tumor cells. We propose to improve CAR T cell therapy by
enhancing metabolic fitness to outcompete GBM cells for nutrients like glucose.
Methods: Our approach will be to directly target the first step of glucose metabolism (i.e., uptake) by permanent
overexpression of GLUT1 or GLUT3 and generating the following CAR T cells: CD70CAR.G1 and CD70CAR.G3.
The murine model of glioma KR158B, derived from Nf1;Trp53 mutant mouse, that we engineered to express
CD70 as well as CD70 expressing human GBM patient-derived cell lines will be used for the following aims:
Specific Aims
1. Investigate the phenotypic and functional characteristics of metabolically modified CD70CAR T cells,
2. Evaluate in vivo the metabolic TME of animals treated with CD70CAR.G1 or CD70CAR.G3,
3. Examine the safety and anti-tumor efficacy of CD70CAR.G1 or CD70CAR.G3.

Public health relevance
NARRATIVE The metabolic switch observed in GBM leads to increased glycolysis in tumor cells and impacts the tumor microenvironment, which in turn acts as a major barrier for successful targeting of cancer by anti-tumor immune cells like T cells. The tremendous increase in tumor glucose consumption imposes a great metabolic pressure on T cells, which experience glucose restriction. The overarching goal of this project is to manipulate the metabolic fitness of chimeric antigen receptor (CAR) modified T cells to ameliorate their tumoricidal activity in the context of immunotherapy to treat GBM